Supporting Patients and Family Care Partners to Manage Chronic Kidney Disease Together

PROJECT SUMMARY
Candidate: Nicole DePasquale, PhD, MSPH, is an Assistant Professor at the Duke University School of
Medicine and is fully committed to becoming an independently-funded investigator at the intersection of
family science and disease management. Her long-term career goal is to develop family-centered interventions
that optimize individual and dyadic health and well-being among older patients with chronic disease and their
family care partners. Dr. DePasquale’s multidisciplinary background makes her an ideal candidate to merge
these two largely separate areas of inquiry. Her academic, research, and training experiences to date span the
fields of communication, psychology, sociology, public health, and human development and family studies, and
her research experiences have been both quantitative and qualitative in nature.
Career development and training plan: Dr. DePasquale’s career development and training plan feature a
multidisciplinary mentoring team comprising a general internist/clinical epidemiologist, geriatrician, health
services researcher, biostatistician, social/health psychologist, and board-certified nephrologist. This team will
support her pursuit of activities that address gaps and strengthen under-developed areas in her experience
through a training plan focused on: 1) geriatric nephrology, 2) dyadic disease management, 3) advanced
quantitative and qualitative research methodology, 4) intervention science, and 5) professional and scholarly
development (best research practices, research collaborations, leadership, and grant writing). Additional
resources to foster her career development and facilitate achievement of her training goals include Duke’s
Claude D. Pepper Center; Edward R. Roybal Center; Offices for Faculty Development, Scientific Integrity, and
Research Mentoring; Social Science Research Institute; and Clinical Research Training Program.
Research plan: The proposed research will use different methodological to address the overarching objective of
understanding the ways in which older patients and their family care partners manage the full course of
chronic kidney disease (CKD) together, and how dyadic management affects individual and dyadic health and
well-being: 1) quantify associations between care partner help with CKD self-management and patient self-
management, depressive symptoms, and health-related quality of life over time (secondary data analysis); 2)
investigate the interrelations of dyadic disease appraisal, disease management, and health along the continuum
of CKD progression (primary data collection through interviews); and 3) adapt and test the feasibility of
SHARE for CKD, a care planning intervention to help patient-care partner dyads work together to manage
CKD. The goal of this work is to initiate a shift in focus from individual experiences and outcomes related to
CKD self-management to those of both members of the care dyad, which can then be used to assist research,
clinical care, and health policies in better supporting patients and care partners alike. Findings will provide Dr.
DePasquale with preliminary data to refine her intervention and test its effectiveness in a R01-funded trial.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease is a progressive, life-altering condition characterized by substantial burden, increased health care costs, and disproportionate prevalence in older adults. Because older adults often require support from family care partners to self-manage chronic disease, it is critical to acquire an understanding of how to best support both patients and their care partners as they work together to manage the full course of chronic kidney disease. This proposal leverages existing resources, uses multi-method approaches, and proposes data collection to understand the different ways in which older patient-family care partner dyads work together to manage chronic kidney disease over time and the impact of shared disease management on health and well- being at both the individual- and dyad-level; this information will then be used to adapt and test the feasibility of a novel, family-centered intervention designed to jointly benefit patients and family care partners.